Predoctoral and Postdoctoral Training Program in Aging and Dementia

Abstract
This proposal is a request for continued funding of a broadly based predoctoral and postdoctoral Mechanisms
of Aging and Dementia Training Program from the Northwestern University Interdepartmental Neuroscience
Program (NUIN). Funding to support four advanced predoctoral candidates, after they have begun full-time thesis
research, and four postdoctoral trainees in early or later stages of training, is requested. Training duration will
be for two years with a goal to assist trainees in submitting and obtaining support from individual research
fellowships following training grant support. This training program developed from a multidisciplinary group of
investigators whose work focuses on the mechanisms of aging and dementia, including Alzheimer's Disease
and related disorders, frontotemporal degeneration, Parkinson's Disease and Amyotrophic Lateral Sclerosis,
with approaches spanning molecular, cellular, systems, behavioral, neuropsychological and clinical
neuroscience. These faculty are affiliated primarily with NUIN and the Mesulam Center for Cognitive Neurology
and Alzheimer's Disease, which has an NIA supported Alzheimer's Disease Research Center grant. The program
will be co-directed by Robert Vassar, PhD, and Sandra Weintraub, PhD, in a Multi-PI format. They will have the
assistance of Thorsten Kahnt, PhD, and Hongxin Dong, PhD, as Associate Directors, an internal Steering
Committee and an External Advisory Committee. The four predoctoral and four postdoctoral trainees will conduct
their research under the guidance of 48 preceptors from 13 departments of 3 schools on the Chicago and
Evanston campuses of Northwestern University, and one from Rush University Medical School. Predoctoral
trainees will be selected from NUIN and the other participating PhD programs on the basis of course
performance, research rotation evaluations, and the relevance of proposed dissertation research. Postdoctoral
trainees will be selected on the basis of previous training and a research plan. Special consideration will be given
to trainees whose research plans are interdisciplinary and carried out in more than one preceptor laboratory. A
concerted effort will be made to recruit trainees from under-represented backgrounds. The program will offer a
broad range of interdisciplinary research and training opportunities in both the fundamental and clinical
approaches to aging and dementia research. The preceptor faculty will assist and monitor trainee progress
through formal advising and evaluations, through the classroom and through informal discussions. In addition to
providing research training, the program will help trainees develop skills in written and oral communication, grant
writing, networking, career development and techniques for insuring reproducibility and accuracy of research
findings. Instilling a clear awareness of ethical issues facing neuroscientists and responsible conduct in science
will be another training goal.

Public health relevance
Narrative Diseases associated with the aging brain, including Alzheimer's, Parkinson's, and ALS, which cause dementia and other symptoms, severely compromise the quality of life for those afflicted and those close to them. This Training Program seeks to provide young predoctoral and postdoctoral scientists the training they will need to become leaders in the field of aging and dementia research. By understanding the basic processes of brain aging, it will be possible to also understand what goes wrong in the devastating diseases that afflict so many.